INSULIN SENSITIVITY IN BOYS WITH DELAYED PUBERTY--TESTOSTERONE/GROWTH HORMONE

Boys with delayed puberty are more insulin sensitive than historical pubertal controls and we hypothesize that testosterone secretion is in part directly responsible for insulin resistance occurring at onset of puberty in boys.